Fostering patient-oriented research in cardiometabolic disease pathogenesis and prevention

ABSTRACT/PROJECT SUMMARY
The overarching goal of this proposal is to facilitate mentored training of junior investigators in the conduct
of high-quality translational research into prevention of cardiometabolic disease. The PI is now Professor of
Medicine at the University of Washington and guides a research program that is focused on the neurobiological
basis of obesity, diabetes, and cardiovascular disease risk. The current proposal broadens the impact of this
work by extending the existing program toward research focusing on understanding neurobiological factors that
promote health, particularly in young children. It investigates the mechanistic basis of preventive dietary
strategies that could alter trajectories of adiposity gain and ultimately reduce risk of cardiometabolic disease over
the lifespan. The candidate’s background includes productive research mentorship of Fellows and junior faculty
clinician-investigators, including K awardees. During this award, the PI will mentor a spectrum of trainees from
fields including endocrinology and metabolism, pediatrics, and nutrition. The PI will take didactic mentoring
courses and engage with experienced senior investigators to build skills necessary for the conduct of the
research. The PI’s research program is currently focused on translational studies of cellular processes consistent
with possible damage to the primary body-weight and glucose-regulating region of the hypothalamus—the
arcuate nucleus. Studies in rodent models show that diet-induced weight gain is dependent on an inflammatory
cellular response, known as gliosis, within the arcuate nucleus of the hypothalamus. Importantly, the PI has
shown that gliosis is detectable in mice and humans by magnetic resonance imaging (MRI). Using MRI, the PI
discovered the first evidence of hypothalamic gliosis in humans with obesity. The PI and trainees have shown
that hypothalamic gliosis 1) is independently related to insulin resistance and type 2 diabetes in humans, 2)
correlates with increased levels of visceral fat, 3) is present in children with obesity, and 4) predicts adiposity
gain in children as well as worsening insulin sensitivity in adults. Funded projects investigate dietary antecedents
of hypothalamic gliosis and its reversal by obesity treatment. The proposed research pivots toward an emphasis
on prevention and intervention strategies that have the potential to modify the underlying neurobiological
processes that drive cardiometabolic risk in obesity. Aim 1 tests the effect of high diet quality feeding on a
radiologic marker of hypothalamic gliosis in children. Aim 2 evaluates the feasibility and acceptability of feeding
intervention strategies that improve diet quality for low-income families with children with overweight or obesity.
Completion of the Aims could provide fundamental insights into the central nervous system’s role in preserving
cardiometabolic health and lay the groundwork for future intervention studies in pediatric populations. Moreover,
the projects provide a breadth and depth of opportunities for promising trainees to gain the experience necessary
to perform high-quality, patient-oriented research on cardiometabolic disease prevention.

Public health relevance
PROJECT NARRATIVE The current proposal addresses obesity and cardiometabolic disease, among the most significant modifiable risk factors for cardiovascular disease in the United States. The proposed research will provide advanced-level training of physicians by an experienced mentor and scientist, thereby producing the next generation of patient- oriented researchers to conduct high-quality studies of cardiovascular disease development and prevention in humans.